Integrated Training in Pharmacological Sciences

PROJECT SUMMARY
This is a renewal application of a training program at Icahn School of Medicine at Mount Sinai that is currently
in its 17th year. In previous project periods, we have developed an innovative program in pharmacological
sciences that has helped to establish Mount Sinai as one of the leaders in the nascent field of systems
pharmacology. We were early advocates of introducing quantitative and computational training for all PhD
candidates in biomedical sciences, and this remains the cornerstone principle of our curriculum. In coursework,
students apply quantitative/computational approaches through problem solving and active learning exercises,
and fundamental biological concepts underlying drug discovery and drug action are communicated within a
disease context that promotes engagement. In addition to the rigorous and innovative curriculum, trainees in
our program benefit from activities that enhance the research experience, including journal clubs, Works-in-
Progress seminars, an annual retreat focused on career development, and an annual systems pharmacology
symposium that provides networking opportunities. The coming project period will build on these successes
and introduce new initiatives including flipped classrooms to maximize trainee flexibility, a new course that will
be co-taught by pharmaceutical industry scientists, and formal training for all program mentors.
For dissertation research, trainees can be mentored by any of 42 well-funded investigators with expertise in
approaches in varied areas of pharmacology such as structure-based drug design, mathematical modeling of
pathophysiology and drug action, and bioengineering. Students address cutting edge issues that must be
solved to develop safe and effective therapeutics in disease areas such as cancer, cardiovascular disease,
neurological disorders, diabetes, and kidney and liver disease. This structure has proven highly effective at
producing successful young scientists. Trainees who have completed the program during the past 10 years
have finished their PhDs in an average of 5.1 years and have typically produced nearly 5 total publications
(average 4.88) and over 2 first author publications (average 2.2) resulting from their time in training at Mount
Sinai. Program alumni have gone on to successful careers that collectively address many aspects of
pharmacological sciences, both in academia and in the pharmaceutical industry. We aim to continue to
innovate and develop trainees who will become tomorrow’s leaders in pharmacology and address the urgent
need for new approaches in drug development.

Public health relevance
PROJECT NARRATIVE The Integrated Training in Pharmacological Sciences program at Mount Sinai aims to train the next generation of leaders in drug development. Predoctoral students complete rigorous, quantitative coursework and are mentored in dissertation research by faculty who are leaders in their fields. Trainees who complete the program are poised for success in fields such as systems pharmacology and structure-based drug design.